Candida-Associated Denture Stomatitis: A Novel Preventative Approach in an Experimental Aging Rat Model of Oral Infection

PROJECT SUMMARY The overall goal of this proposal is to identify a novel preventative approach targeting an oral condition prevalent in the edentulous population. Denture stomatitis caused by the oral fungal pathogen Candida albicans, is a common oral condition prevalent in up to 70% of denture wearers causing severe pain impairing the ability to eat and speak. This debilitating disease tends to be persistent and recurrent as a consequence of the ability of C. albicans to adhere and form biofilms on denture surfaces and associated oral tissue. Despite its prevalence, there are currently no strategies available for the prevention of denture stomatitis. Natural antimicrobial peptides have attracted significant attention due to their broad-spectrum activity and lack of toxicity. Histatin-5 (Hst-5) is particularly attractive as it is potent in killing C. albicans. To that end, we recently designed a bioadhesive hydrogel delivery system specifically for oral topical application and using Hst-5 as a blueprint, we also engineered a novel variant. Our preliminary investigations demonstrated the ability of the peptide variant in preventing C. albicans adherence and biofilm formation on denture acrylic material in vitro. Importantly, by taking advantage of new technological advances in dentistry available to us, we digitally engineered and fabricated a universal intraoral acrylic device for rats. The model was specifically designed to study Candida biofilm formation on installed oral devices, and ensuing tissue infection and inflammation, mimicking clinical denture stomatitis in humans. In this proposal, we aim to demonstrate the clinical utility of the novel formulation against denture stomatitis in an aging rat model. We expect the fulfillment of the aims of this proposal to identify a feasible approach for the prevention of biofilm-associated oral infections, and specifically denture stomatitis, which continues to be a public health problem particularly in the pre-disposed edentulous elderly population.

Public health relevance
NARRATIVE Denture stomatitis is a debilitating oral disease caused by the fungal pathogen Candida albicans. Although this condition is prevalent in up to 70% of denture wearers, there are currently no strategies available for its prevention. We recently designed a bioadhesive hydrogel delivery system and a peptide specifically for oral topical application and we demonstrated the ability of the formulation in preventing adherence of the fungus to denture material. Importantly, we also fabricated an intraoral device for rats to develop an animal model of oral infection that mimics the disease process in humans. In this proposal, we will use the animal model to demonstrate the efficacy of the formulation against denture stomatitis. We expect this project to lead to the identification of a novel approach for the prevention of denture stomatitis, which continues to be a public health problem particularly in the elderly.